Smartphone-based Retinal Imaging for Diabetic Retinopathy Detection in Egypt

Project Summary: Diabetes affects 537 million adults globally in 2021, with 75% residing in low- and
middle-income countries (LMICs). Diabetic retinopathy (DR) is a common complication of diabetes and
manifests as retinal vein bleeding. Almost 10% of people with diabetes can progress to vision threatening
DR without any symptoms so it is crucial to be evaluated by retinal screening and referred to a doctor.
Since bulky and expensive fundus cameras are not suitable for fast DR screening in LMICs, there is an
urgent need for portable and inexpensive retinal imaging systems. Recent technical innovations make
use of smartphones as imaging devices to capture retina images but existing automated algorithms for
image analysis are only designed for high-quality fundus cameras. Therefore, we propose an innovative
provider-performed solution for smartphone-based retinal imaging to analyze images using deep learning
for DR screening in an LMIC, as a case study in Egypt (DR prevalence of 20%).
The primary objective of our study is to contribute to efforts to improve the technical capability and clinical
practice for DR screening in Egypt, increase the rate of access to DR imaging, ultimately reduce the
blindness. We intend to achieve this objective by pursuing two specific aims in the R21 phase to establish
initial feasibility. First, we will attach a retinal imaging device to smartphones, creating a portable and
cost-effective imaging system while optimizing image quality through contrast and sharpness
enhancements. Second, since multiple images will be captured from smartphone-based retinal imaging
systems to cover whole retina due to limited field of view, we will develop CNN-based deep learning
algorithms to analyze the DR formation in these multiple images and fuse the decisions in score and
feature levels. Upon successful completion of R21 milestones, the R33 phase will focus on further
validation and effectiveness studies, with two specific aims. We will first utilize collaborative approaches
and employ trustworthy WisdomNet architecture to improve model performance. Second, we will embed
the knowledge into deep learning frameworks using attention map mechanism. Instead of using only
labels to train the deep networks, we will also use the location of suspicious retinal regions during training
to focus on these regions. This approach enhances model performance and provides explanatory insights
crucial for assisting doctors in DR diagnosis and prioritizing cases for further examination.
This project will enable fast DR screening in LMIC general healthcare facilities such as urban areas,
remote clinics, and pharmacies. With this project, we will have the potential to distribute quality eye care
to underserved areas lacking access. In the long term, we will expand this smartphone-based retinal
imaging system to other LMIC and to screen for other eye diseases.

Public health relevance
Project Narrative Diabetic people are at high risk of eye disease, including diabetic retinopathy where untreated DR may result in varying degrees of vision lost and even blindness. Since the early detection could improve the chances of effective treatment to prevent blindness, people with diabetes must have annual eye exam. This project will develop a smartphone-based portable and affordable retinal imaging system to detect DR formation using machine learning.